Characterizing a transcriptional control region within the Type I interferon gene cluster

PROJECT SUMMARY
Type I interferons (IFN-I) provide the first line of defense against viruses and play a pivotal role in coordinating
the innate and adaptive immune responses. The presence of infectious viruses triggers a cascade of events
leading to the activation of IFN-I genes that further induce the expression of a large battery of antiviral proteins.
This antiviral program is something that must be selectively induced only when appropriate as chronic
signaling is associated with severe inflammatory phenotypes and autoimmunity. These so called
‘interferonopathies’ are a clinically heterogenic group of diseases that are becoming increasingly recognized
and speak to the importance of silencing the IFN-I locus in the absence of infection. Here we propose to
define how a conserved gene called Kelch-Like Family Member 9 (KLHL9), which is found in the center of the
IFN-I gene cluster, ensures the transcriptional repression of the region in the absence of virus infection. This
proposed research will advance the understanding of how the IFN system functions at the center of immune
and inflammatory diseases, and should also lead to a better understanding as to the molecular cause of at
least a subset of interferonopathies.

Public health relevance
PROJECT NARRATIVE The battle between cells and the microbes that infect them reflects a long evolutionary history where every defense generated by the host inevitably results in a corresponding counter measure by the pathogen. One such example of this evolutionary conflict is evident in the biology of the vertebrate Type I interferon (IFN-I) system, which has retained many duplicated copies of genes encoding IFN-I subtypes which must remain off at all times in the absence of virus infection to prevent so-called ‘interferonopathies’. This proposal focuses on the characterization of the evolutionary conserved KLHL9 gene and its ability to prevent any spurious transcription from the IFN-I locus in the absence of infection.